Integrating infectious diseases screening and treatment with medication assisted therapy for Veterans with opioid use disorder

Opioid use disorder (OUD) is associated with increased risk for overdose as well as acquisition and transmission
of infectious diseases (ID) via injection drug use, including HIV, hepatitis C virus (HCV), and bacterial sexually
transmitted infections (STI). Previous studies support improved clinical outcomes when integrating treatment for
OUD and screening and treatment of HIV and HCV in non-Veteran populations. However, clinical care for
Veterans with OUD often requires appointments with multiple different healthcare providers. These care silos
place an increased burden on this patient population who often have barriers to appointment attendance.
Improved integration OUD and ID clinical care is needed. In a study of Veterans with OUD who accessed care
at the Northport VA we identified 216 (43%) Veterans who injected drugs and of those, 134 (62%) had HCV and
30 (13.9%) had at least one severe injection related infection requiring hospitalization. We also found low rates
of screening for syphilis (n=371, 74%), gonorrhea (n=160, 31.9%), chlamydia (n=169, 33.7%) and uptake of HIV
pre-exposure prophylaxis (PrEP) (n=4, 0.8%). In order to more thoroughly assess for gaps in VHA care delivery
we must examine ID screening and PrEP uptake in a national cohort of Veterans with OUD who inject drugs.
We must also clarify if there are any provider or Veteran barriers to ID screening receipt or PrEP uptake. For my
CDA proposal I hypothesize that Veterans with OUD who are offered a care model that integrates OUD and ID
clinical care will have increased rates of ID testing completion and initiation of PrEP. In specific aim 1, I will
perform a retrospective study of ID epidemiology in a national cohort of Veterans with OUD who inject drugs.
We will assess the proportion of Veterans who initiate PrEP (subaim 1A), proportion who completed screening
for HIV, HCV and STI (subaim 1B), and compare the proportion of Veterans who received ID testing between
multiple care settings (subaim 1C). Demographic factors (e.g. race/ethnicity, sex, geographic census, rural
versus urban) will also be considered. In specific aim 2, I will complete a qualitative assessment of healthcare
provider and Veteran specific barriers to uptake of ID screening and/or PrEP. Semi-structured interviews will be
completed with providers in ID, primary care, and substance use disorder (SUD) clinics about knowledge of
indications for screening for ID and PrEP in Veterans with OUD, as well as barriers to care delivery (subaim 2A).
Veterans with OUD will be interviewed to inquire about experiences with receipt of ID screening and barriers to
receipt of PrEP or ID screening at the Northport or West Haven VAs (subaim 2B). In specific aim 3 I will implement
a pilot study that assesses feasibility and acceptability of an integrated ID screening and PrEP intervention for
Veterans with OUD who are engaged in care through the Northport VA SUD clinic. We will randomize Veterans
to receive either integrated care (HIV, HCV, STI screening and/or PrEP plus SUD care) or treatment as usual
(SUD care plus ID clinic referral). We will compare rates of HIV, HCV and STI screening (subaim 1) as well as
PrEP uptake (subaim 2) between the groups. This research will benefit male and female Veterans with OUD.
This project will be carried out at the Northport Veterans Affairs Medical Center (NVAMC) (AIMs 1 and
3), the VA Connecticut Healthcare System (virtually or by phone, AIM 2), plus two additional VA sites (AIM 2),
locations to be determined by AIM 1, under the co-mentorship of Drs. Sandra Springer (VA Connecticut) and
Bettina Fries (NVAMC). Drs. Springer and Fries are experts in infectious diseases and are federally funded
investigators with experience in clinical research. Both will guide my career development along with an advisory
committee. Completion of the proposed project and career development plan will allow me to fulfill my short-term
goals of gaining additional training in clinical research and long-term goals of becoming an independent
physician-scientist, practicing infectious diseases (25%) and performing clinical research (75%) at the NVAMC.
In addition to robust ID clinical training, I have the necessary research foundation to fulfill these goals including
1) ID clinical research training 2) Master of Public Health degree 3) Demonstrated publication success.

Public health relevance
Opioid use disorder (OUD) is on the rise in Veterans, which is associated with overdose and death. Injection of opioids is especially harmful and is associated with acquisition and transmission of infectious diseases which may have long-term health consequences in both male and female Veterans. Treatment of OUD with medication assisted therapy is highly effective, however this often occurs independently of infectious diseases clinical care for Veterans at risk for HIV and other infections. The project proposes to integrate care for both infectious diseases and OUD within a single clinical setting, which would both improve the health of Veterans and would reduce the cost and time burden for Veterans who often need to attend multiple outpatient appointments.